Targeting the alpha secretase ADAM10 for the treatment of Alzheimer's disease

Summary/Abstract
Alzheimer’s disease (AD), one of the most prevalent degenerative diseases, is characterized by
the prevalence of senile plaques that consist of fibrils of amyloid b (Ab). In the amyloidogenic pathway,
sequential proteolysis of the b-amyloid precursor protein (APP) by b and g secretases generate Ab (40-
42 amino acid) peptides. Ab multimerizes into neurotoxic oligomers that target the synapse, leading to
disruption of long-term potentiation, cell death, and memory loss. Alternatively, in the non-amyloidogenic
pathway, APP is cleaved sequentially by a and g secretase to generate sAPPa that exhibits
neuroprotective properties and precludes the formation of Ab. Studies have identified ADAM10, a
member of the adamlysin family of zinc metalloproteinases, as the constitutive a-secretase in neurons.
Activation of ADAM10 is currently being evaluated as a means of therapeutic intervention. However, this
strategy has severe disadvantages: ADAM10 is known to cleave multiple substrates and is upregulated
in a wide range of malignancies. A non-specific (non-selective) up-regulation/enhancement of ADAM10
as a means of therapeutic intervention in AD would likely have deleterious side effects. The importance
of the non-catalytic (disintegrin and cysteine rich) domains of ADAM10 in substrate recognition was
shown previously. A conformation specific mAb, 8C7, which recognizes an active conformation of
ADAM10 found on tumor cells was developed. Importantly, while 8C7 selectively enhances APP
cleavage in cell-based assay, it inhibits Notch-Delta and Eph-ephrin oncogenic signaling in preclinical
models, without any discernible toxicity effects in mice, thereby ruling out deleterious side effects that
might result from its potential use as AD therapeutic. The proposed studies will characterize the
ADAM10-APP interactions in vitro to better understand how the ADAM10 a-secretase interacts with and
cleaves APP. The molecular mechanism of action of the 8C7 mAb in promoting this cleavage will also
be investigated. A human version of the anti-ADAM10 mAb 8C7, named 1H5, that augments cleavage
of peptide substrates and binds to the substrate binding domain of ADAM10, was generated recently.
Similar to 8C7, this human mAb (1H5), as well as a single-chain variable fragment (scFv) derived from it,
will now be evaluated in cell-based assays in order to determine their efficacies in promoting APP
cleavage. The shedding of APP will further be examined in rat neuronal and human glioblastoma cell
lines in the presence of the mAbs (8C7 and 1H5) and the scFv. This proposal, to enhance the non-
amyloidogenic pathway with anti-ADAM10 mAbs towards the development of novel AD treatments,
serves as a proof of principle of therapeutic potential.

Public health relevance
Narrative The research in this proposal will provide proof of concept for a novel approach for the treatment of Alzheimer’s disease using monoclonal antibodies. Specifically, we propose to develop conformation-specific monoclonal antibodies, which bind the a secretase ADAM10, activate amyloid precursor protein cleavage, and promote the non-amyloidogenic pathway in cell- and neuron-based assays. The studies will also provide the first high-resolution structural view of how ADAM10 interacts with and cleaves the amyloid precursor protein.